Posttranslational Regulation of Cell Growth and Stress Responses

Project Summary
A central goal in disease biology is to describe the molecular processes responsible for transformation
of a cell from a normal state into a pathological one. Compared to the rapid progresses in DNA and RNA
sequencing technologies, characterization of the final and arguably most actionable element of the central
dogma, protein, has lagged behind. The dynamic relationship between the genome of a cell and its proteome
is poorly understood, reflecting multiple layers of transcriptional/post-transcriptional regulation. In particular, the
complexity of the human proteome is greatly expanded by the ~400 different types of protein posttranslational
modifications (PTMs). The various PTM events, either alone or in combination (i.e., “cross-talk”), represent
powerful mechanisms to modulate the function of a protein (e.g., activity, stability and localization), the
collection of which convey information within the signaling network that underlies the complex traits in various
pathophysiological conditions. However, because of many inherent technical difficulties associated with the
analysis of protein PTMs (e.g., chemically diverse, unstable and low abundance), a complete description of the
posttranslationally modified proteome of any given cells remains a daunting task. The overarching mission of
our program is to: (1) develop cutting-edge quantitative proteomic approaches to systematically identify and
characterize novel PTMs, (2) comprehensively interrogate the signaling events regulated by phosphorylation
(mTOR pathways) and ADP-ribosylation (PARP pathways), and (3) combine these systems biology
approaches with classical biochemical, cell biology and animal experiments to decipher the molecular
underpinnings of cell growth and stress responses that are controlled by these two important pathways. To
accomplish these goals, we will leverage our preliminary results (including a large set of unique hits, reagents
and methods), and center our efforts on the following six goals. First, we will develop innovative mass
spectrometric technologies with dramatically improved performance for global, quantitative and site-specific
analysis of novel PTMs. Second, we will investigate the role of IGFBP5 (a recently identified extracellular target
of mTORC1) as a mediator of the “non-cell autonomous” function of mTORC1. Third, we will determine the role
of EGR1 (a novel hit identified from our previous MS screen) as a master regulator of the mTORC1-dependent
feedback loops. Fourth, we will generate a tissue-specific atlas of mTORC1 phosphorylation substrates, and in
doing so, interrogate non-uniform effects of this important pathway on the physiology of different tissues. Fifth,
we will develop a large-scale MS approach to site-specific characterization of the D/E-mono-ADP-ribosylated
proteome, and finally we will develop a large-scale method to measure absolute protein PARylation
stoichiometries. Together, these studies provide a comprehensive framework for the MS identification and
functional characterization of PTMs events linked to cell growth control and stress responses.

Public health relevance
Although our understanding of disease biology as it relates to the central dogma (DNA-RNA-Protein) has been buoyed by rapid technological advances in DNA and RNA sequencing technologies, quantitation of the final and arguably most actionable element of the central dogma, protein, has lagged behind. In this proposal, we will develop cutting-edge, mass spectrometry-based proteomic technologies, and combine them with biochemical, cell biology and animal experiments to study various protein posttranslational modifications (in particular, phosphorylation and ADP-ribosylation) that are related to cell growth control and stress responses. In so doing, we will uncover signaling mechanisms that will lead to better therapeutic intervention strategies for the treatment of relevant human diseases.